The role of DNA damage and repair at telomeres

Uracil in the genome can result from misincorporation of dUTP instead of dTTP during DNA synthesis, and is primarily removed by uracil DNA glycosylase (UNG) during base excision repair. Telomeres contain long arrays of TTAGGG repeats and may be susceptible to uracil misincorporation. Using model telomeric DNA substrates, we showed that the position and number of uracil substitutions of thymine in telomeric DNA decreased recognition by the telomere binding protein. In primary mouse hematopoietic cells, uracil was detectable at telomeres, and UNG deficiency further increased uracil loads and led to abnormal telomere length in mice. Enhanced uracil substitutions of thymine in telomeric DNA also result in alterations/aberrations in other aspects of telomere maintenance, especially in the absence of telomerase. Thus, accumulation of uracil and/or UNG deficiency interferes with telomere maintenance, thereby underscoring the necessity of UNG-initiated base excision repair for the preservation of telomere integrity. Our long term goal is to investigate the role of uracil misincorporation and BER deficiency in telomere dysfunction-induced cellular senescence and organismal aging in mice and human cells.